CD8+ TRM Development and Maintenance in the Upper Respiratory Tract

PROJECT SUMMARY / ABSTRACT
Influenza infection imposes a substantial burden on global health, with several million infections and hundreds
of thousands of deaths annually. Current influenza vaccination strategies offer limited seasonal protection due
to changing influenza virus epitopes and the appearance of novel and/or pandemic potential strains that may
thwart pre-existing influenza immunity mediated by antibodies. CD8+ tissue-resident memory T cells (TRM)
afford optimal protection against heterologous influenza strains, as these cells target highly conserved influenza
epitopes that remain relatively unchanged year-to-year. CD8+ TRM reside in the upper respiratory tract (URT),
comprised of the nasal cavity, larynx, and pharynx, and the lower respiratory tract (LRT), containing the airways
and lungs. URT CD8+ TRM are critical for limiting viral replication and preventing severe LRT infection, which
leads to significant morbidity and mortality. The requirements for development of CD8+ TRM in the LRT are well
understood. Prior work shows that local antigen recognition and specific signals in the lung microenvironment
are required for LRT CD8+ TRM formation. However, the signals that drive URT CD8+ TRM development,
particularly in the absence of local antigen, have not been extensively characterized. This proposal aims to
identify the requirements for URT CD8+ TRM development in the presence or absence of local antigen (ie, after
parenteral vaccination). Preliminary data shows that a mouse model of intranasal (i.n.) versus intraperitoneal
(i.p.) influenza infection induces URT CD8+ TRM with and without local antigen, respectively. Further, initial
studies demonstrate that URT CD8+ TRM cannot form in the absence of local antigen and TGF-b signaling. We
will leverage this i.n. versus i.p. infection system to investigate the role that TGF-b, IL-15 and IL-33 cytokine
signaling play in URT CD8+ TRM formation. Initial in-vivo mouse studies demonstrate that LRT CD8+ TRM
induced in the presence of local antigen decline over time, while URT CD8+ TRM remain stable up to 6 months
after i.n. and i.p. priming. We will utilize a tamoxifen-inducible CD103 Cre system and parabiosis model to
investigate mechanisms of URT CD8+ TRM maintenance over time with and without local antigen. We will
additionally employ an adoptive transfer model to assess URT CD8+ TRM localization and maintenance in the
absence or presence of local antigen via immunofluorescent microscopy. This work will define signals required
for optimal formation and maintenance URT CD8+ TRM, which will offer critical insights to improve vaccination
strategies for preventing severe influenza disease and inducing protective immunity against other respiratory
viruses.

Public health relevance
NARRATIVE Global influenza vaccination strategies need improvement due to limited seasonal efficacy resulting from changes in surface proteins of the circulating influenza virus variants. Upper respiratory tract CD8+ tissue- resident memory T cells (TRM) offer durable protection against influenza since these cells target highly conserved, internal influenza epitopes. This proposal aims to define the signals that mediate CD8+ TRM development, maintenance, and longevity in the upper respiratory tract, which will inform respiratory virus vaccination efforts to limit severe respiratory tract infection.